Washington University SummeR reseArch DIversity ProgrAm iN Cardiovascular Disease & HEmatology (RADIANCE)

PROJECT SUMMARY/ABSTRACT
This R25 Short-Term Research Education Program to Enhance Diversity in Health-Related Research titled
“Washington University (WU) SummeR reseArch DIversity ProgrAm iN Cardiovascular Disease & HEmatology
(RADIANCE)” proposal is in response to RFA-HL-22-012. We build upon our extensive experience with two
currently-existing programs: 1) NHLBI-funded “Programs to Increase Diversity among Individuals Engaged in
Health-Related Research (PRIDE)”, which focuses on nationally underrepresented in medicine (URM) junior
faculty; and 2) WU Institute for Public Health Summer Research Program (IPH-SRP) – Public and Global Health
Track that has trained undergraduate and health professional students in health research for past eight years.
Our excellent track-record with these summer research programs and established infrastructure allows for
seamless program expansion and integration. Cardiovascular disease (CVD) and Hematologic Disorders
are leading causes of morbidity and mortality in the US and globally. Disparities in diagnosis and treatment of
both CVD and Hematologic Disorders are highly prevalent. We propose to recruit, provide training, mentoring
and career development and research skills to undergraduate and health professional students (total: 12 URM
trainees/year) who are individuals: A) from racial/ethnic groups traditionally underrepresented in health-related
sciences on a national basis; B) with disabilities; and C) from disadvantaged backgrounds, through the following
OBJECTIVES: Objective 1. To recruit, train, mentor, and engage a diverse URM students group with interests
in exploring research careers, thorough a multidisciplinary approach necessary to advance research on CVD
and Hematologic Disorders. Objective 2. To provide rigorous didactics, structured mentoring and hands-
on research experiences that foster knowledge, attitudes, and skills in biomedical, behavioral, and clinical
research. Objective 3. To expose and nurture trainee interests in research, academic and professional
development in CVD/Hematologic Disorders and to provide research experiences that will help inform future
career and training opportunities. Objective 4. To prepare, under guidance from mentors and program
leadership, a “capstone experience” summary presentation at the end of the program that synthesizes the
trainee learning and research experience. The overarching goal of RADIANCE is to provide creative and highly
relevant educational activities with primary focus on research experiences and mentoring activities for enhancing
diversity of the biomedical research workforce. The goals of this proposal align with scientific priorities of NHLBI
to: 1) provide broad CVD/Hematologic Disorders teaching and research training; 2) provide scientific
research foundation for trainees; 3) ensure equitable & inclusive program access and participation of diverse
US populations. NHLBI-funded WU Program & Mentoring Faculty will offer excellent experiences for mentees.
We are optimistic that this proposal will help enhance the diversity of the research workforce in areas of
importance to the NHLBI mission.

Public health relevance
PROJECT NARRATIVE This training program aims to provide training and mentoring to a diverse group of undergraduate and health professional students from racial/ethnic groups traditionally underrepresented in health-related sciences on a national basis. The students will participate in scientific research, academic and professional development program in cardiovascular disease and hematologic disorders to help enhance the diversity of the next generation of leaders in the biomedical, behavioral and clinical research workforce in the topical areas of relevance to NHLBI.